SCREENING FOR ENTRY INTO PSORIASIS STUDIES

This protocol is intended to cover screening of individuals for treatment of their psoriasis when those individuals do not enter a study, for one reason or another. These are not "off-protocol" visits, but neither can the visit(s) be attributed to a particular protocol. With new patients a medical history is obtained, the skin is examined visually, the nature of participation in research studies is discussed. Current protocols are described. With old patients the skin is examined, interim medical history discussed and current protocols are described. No biopsies are taken or blood drawn; other protocols cover these activities. If individuals enter a particular study the screening visit is attributed to that protocol. Some people may be potential candidates for a later but not current study, and some individuals are deemed unsuitable for any study; in both these cases we would attribute the visit to this screening protocol.